Statistical Methods for Addressing Disease Under-diagnosis Using Electronic Health Record Data

Under-diagnosis occurs when an individual living with a disease condition has not
received a diagnosis. Reasons for under-diagnosis are often complex and context
specific, and the extent may vary across sensible population subgroups leading to
disparity in care. Electronic Health Records (EHRs) contain a wealth of health
information for patients, and the diagnosed and under-diagnosed patients may bear
similarity in their EHR profiles, which differ from those condition-free. Therefore,
EHRs provide a unique opportunity to address under-diagnosis in the standard
healthcare setting. Full exploitation of such opportunity is challenging, however,
because of the very fact that under-diagnosed patients are embedded in the large
number of condition-free patients. Noting that patients who have been diagnosed
with the condition can be identified from EHRs, we propose that EHR data, when
enriched with additional disease labels from a small scale targeted screening, allows
development of data-driven approaches to identifying under-diagnosed patients and
assessing disparity in under-diagnosis. To this end, we will develop an arsenal of
statistical and machine learning methods and accompanying software tools to
address under-diagnosis. Our methods enable (1) a risk-based approach to
identifying patients in EHRs who most possibly miss the diagnosis (Aim 1); (2)
unbiased comparison between diagnosed and under-diagnosed patients to
understand disparity in under-diagnosis (Aim 2); and (3) leveraging of existing
models and targeted screening data to address under-diagnosis in a new clinical
setting. We will apply the developed methods to address under-diagnosis in Primary
Aldosteronism and Familial Hypercholesterolemia using data from Penn Medicine
and VA EHRs.

Public health relevance
Under-diagnosis occurs when an individual living with a medical condition has not been diagnosed. Overlooking of diagnosis prevents patients from opportunities of appropriate treatments and prevention strategies, and often is more serious in some population subgroups. Recent emphasis on electronic health records (EHRs) provides a unique opportunity for addressing under-diagnosis, which to date remains largely unexploited due to lack of suitable analytical methods. The overarching goal of this project is to develop data-driven methods to accurately identify patients from EHRs who possibly miss their diagnosis and provide insights for reasons of under-diagnosis.